COMPUTER AIDED DRUG DISCOVERY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Our research goals are to develop novel approaches for computer-aided drug discovery and to deliver application packages for biomedical developments and research.